Engineering Synthetic Biomolecular Condensates for Targeted Autophagy Modulation

PROJECT SUMMARY / ABSTRACT
The modulation of autophagy is a promising target for drug discovery due to its role in various diseases. Current
approaches often result in drugs with unanticipated effects due to the complexity of autophagy signaling
networks, highlighting the need for novel strategies.
Biomolecular condensates (BMCs), membrane-less organelles formed by phase separation, play a key
role in selectively disposing of unwanted proteins via autophagy. Selective autophagy receptors (SARs) function
as BMCs, recruiting degradation-bound cargo to phagophores. For example, p62/SQSTM1 forms BMCs to
regulate autophagosome biogenesis by stabilizing phagophores, a biophysical regulatory mechanism that
correlates the physicochemical properties of BMCs with autophagy efficacy.
Despite advances, the regulatory mechanisms of BMCs in autophagy remain largely unexplored due to
their compositional complexity and transient nature. This poses a barrier to systematically studying the
biophysical interactions during autophagic engulfment. We propose to engineer a novel BMC-based tool with
tunable physicochemical properties using PopTag, a synthetic BMC platform developed in our lab. This will
create an orthogonal SAR-like BMC capable of supporting autophagosome biogenesis and selective cargo
recruitment.
Our approach involves leveraging PopTag's modular domain architecture, which includes the 'condenser'
(drives condensation), the 'tuner' (modulates properties), and the 'actor' (enables recruitment). This platform
allows us to disentangle signaling-based regulatory mechanisms from biophysical ones, enabling detailed
investigation of BMC properties and autophagy.
We will first Investigate the physicochemical properties of p62/SQSTM1. Using confocal microscopy,
fluorescence recovery after photobleaching (FRAP), and microelectrophoresis, we will establish the homeostatic
range of surface tension, viscosity, and surface electrostatics for p62/SQSTM1-mediated autophagosome
biogenesis. We will also assay disease-relevant mutations to identify abnormal physical properties (Aim 1).
Next, we will engineer an orthogonal BMC-based platform for selective autophagy. Using rational protein
design, we will create an autophagy-targeted PopTag (AutoPop) and optimize its physicochemical properties to
enhance autophagosome biogenesis and cargo recruitment (Aim 2).
This proposal aims to establish the foundational physicochemical properties required for autophagosome
biogenesis and develop an orthogonal BMC-based tool for investigating the cellular biophysics of autophagic
engulfment, paving the way for innovative therapeutic strategies targeting the biophysical aspects of autophagy.

Public health relevance
PROJECT NARRATIVE Biomolecular condensates facilitate the formation of autophagosomes, the double-membrane vesicles that engulf damaged or unnecessary cellular components for degradation via the autophagy-lysosomal pathway. Defects in this pathway contribute to various diseases, and enhancing autophagosome formation through pharmacological or genetic interventions is a potential therapeutic strategy for these conditions. Here, we present an approach to engineering a novel biomolecular condensate-based tool that will enable detailed studies into the biophysical aspects of autophagy, establishing a new opportunity to advance innovative biophysical-based therapeutic strategies.